Lipidomics of Pulmonary Vascular Disease

Project Summary/Abstract
Pulmonary arterial hypertension (PAH) remains challenging to treat due to its complex pathobiology. The
persistently high mortality observed in PAH, despite a recent evolution in available pulmonary vasodilator
therapies, underscores a critical need to intervene upon fundamental disease biology. Our data show that
abnormalities in long-chain fatty acid (LCFA) metabolism precede a clinical diagnosis of PAH in the at-risk
scleroderma population. Despite increasing recognition of lipidomic aberrations in PAH, no studies have
examined comprehensive high-resolution lipidomics in relation to measurements of right ventricular (RV) and
pulmonary vascular (PV) function. Our preliminary single-center high-resolution lipidomic data show that lipid
species with LCFA residues are associated with measures of RV-PV dysfunction. LCFAs are known to be
biologically important mediators in the lung, and many are essential FAs obtained via dietary intake. The goal of
the current proposal is to validate our single-center lipidomic observations in external cohorts with
complementary data features and data structures. We hypothesize that the lipidomic signatures detected in our
discovery cohort will reproducibly relate to specific RV-PV phenotypes and clinical outcomes, which will implicate
biologically important aberrations in lipid metabolism that may be targetable via dietary or pharmacologic
interventions. With Aim 1, we seek to validate lipidomic signatures in the larger, multi-center PVDOMICS cohort
of patients with, or at risk for, pulmonary vascular disease, and to investigate lipid gradients across the pulmonary
vasculature (e.g., differences in lipid abundance in blood samples collected from the mixed venous vs. wedged
positions). Our second aim involves validating our preliminary lipidomic signatures in the ARIC cohort, a
longitudinal study of initially healthy individuals followed forward in time. We will explore the relationships
between dietary lipid intake, plasma lipid levels, and RV-PV function, hypothesizing that changes in LCFAs over
time will predict RV-PV function. In Aim 3, we will prospectively follow patients newly diagnosed with PAH. We
will investigate whether lipidomic aberrations, at baseline and in follow-up after initiation of standard PAH-specific
therapy, can outperform traditional clinical measures of treatment response for predicting clinical worsening
events. Completion of this project will yield a detailed understanding of lipid aberrations specific to phenotypes
and outcomes in PH, which has the potential to identify novel biomarkers and therapeutic targets. Should our
hypothesis be confirmed, the project stands to transform our approach to PH management via early identification
of patients at high risk for experiencing poor outcomes, and potential early intervention based on lipidomic
insights.

Public health relevance
Project Narrative Pulmonary arterial hypertension (PAH) remains a significant public health concern due to high mortality rates and limited treatment options. This project investigates the role of highly specific lipid abnormalities in PAH in order to identify novel biomarkers and therapeutic targets. Because many of the lipid abnormalities preliminarily observed may relate to dietary patterns, this project may enable future trials of dietary interventions in PAH, which could bring about improved outcomes and a reduction in the disease's burden on public health.